TITLE: ANALYTICAL CHEMISTRY AND STABILITY TESTING OF TREATMENT DRUGS FOR SUBSTANCE USE DISORDERS. N01DA-19-8950. BASE PERIOD: POP AUGUST 4, 2019 - AUG

The Contractor shall provide services for analytical chemistry and quality controls of drug substances and/or finished dosage forms in support of the National Institute on Drug Abuse's (NIDA) medication development programs.